PIPERACILLIN AND TAZOBACTAM IN BONE

This is an open label, single dose, tissue distribution study assessing the penetration of the combination of piperacillin and tazobactam into bone at one hour after initiation of a 30-minute intravenous infusion in patients undergoing elective total hip replacement. 2 patients were studied (multiple blood and bone).